Molecular mechanisms of programmed necrosis in the ischemic retina

PROJECT SUMMARY
Retinal ischemia-reperfusion (IR) injury is a common cause of visual impairment worldwide, affecting both
patients' quality of life and functional status. Retinal ganglion cell (RGC) survival is critical for vision. However,
these retinal neurons are exquisitely sensitive and many of them undergo necrosis and apoptosis after IR.
Since RGC apoptosis is executed by programmed mechanisms and can be regulated, significant attention has
been given to this type of cell death. At the same time, RGC necrosis did not receive nearly enough
consideration, because it was viewed as an accidental and unregulated cellular event. We now know that
necrosis, like apoptosis, can be executed by programmed mechanisms. This form of necrotic cell death is
called necroptosis. Our published data and literature indicate that RGC necroptosis contributes to IR-induced
retinal injury through direct loss of RGCs and induction of associated inflammatory responses. Therefore, since
RGC necroptosis is executed by programmed mechanisms and can be regulated, this field of research is of
great importance. However, the signaling cascades, which regulate IR-induced RGC necroptosis, still remain
unknown. The long-term objective of this project is to identify the signaling cascades that regulate RGC
necroptosis after IR. Based on our published data, preliminary studies and published literature, we proposed a
molecular mechanism of IR-induced RGC necroptosis. We suggested that IR-induced Tnf signaling in RGCs
facilitates formation of a positive-feedback loop for the sustained production of reactive oxygen species (ROS),
which promotes poly (ADP-ribose) polymerase 1 (Parp1) over-activation due to significant oxidative DNA
damage. Significant Parp1 over-activation in RGCs mediates ATP depletion, leading to subsequent energy
failure, which results in cellular dysfunction and eventually in loss of RGC membrane integrity (necrosis). We
will employ a wide range of biochemical, molecular and cell biological techniques as well as animal models to
verify the proposed molecular mechanism of IR-induced RGC necroptosis in hypothesis-driven mechanistic
experiments outlined in the following specific aims: 1) to test the hypothesis that Tnf signaling promotes IR-
induced RGC necroptosis; 2) to test the hypothesis that IR-induced RGC necroptosis is promoted by formation
of a positive-feedback loop for sustained ROS production in a Tnf signaling-dependent manner; 3) to test the
hypothesis that RGC necroptosis is a result of ATP depletion caused by Parp1 over-activation after IR. Thus,
since treatment for IR is limited in part because of a lack of understanding of the molecular events leading to
RGC death, a greater understanding of RGC necroptosis after IR will lead to new therapeutic strategies for this
important and difficult to treat condition.

Public health relevance
PROJECT NARRATIVE Retinal ischemia-reperfusion (IR) injury is a common clinical condition, which results in necrotic and apoptotic retinal ganglion cell (RGC) death. However, significant attention has been given to IR-induced apoptosis, which can be regulated, but not to necrosis, because it had been viewed as an accidental and unregulated cellular event. We now know that this viewpoint was incorrect and programmed (as opposed to accidental) RGC necrosis can significantly contribute to IR-induced retinal injury through signaling cascades, which will be investigated in detail in the proposed study.